Identifying Viral Markers of influenza Vaccine Escape

To improve influenza vaccine effectiveness by identifying markers of vaccine failure on the virus genome-wide level; to identify evolutionary drivers of emergence and transmission of vaccine escape.